Dissecting FOSL1-mediated lineage plasticity and resistance to androgen receptor signaling inhibition in prostate cancer

PROJECT SUMMARY/ABSTRACT
CANDIDATE: I am a postdoctoral research associate in the laboratory of Dr. Yu Chen in the Human Oncology
and Pathogenesis Program (HOPP) at Memorial Sloan Kettering Cancer Center. My PhD training at Boston
University School of Medicine under the supervision of Dr. Sam Thiagalingam allowed me to develop cellular
and molecular biological skills to functionally characterize candidate genes involved in cancer progression and
investigate therapeutic vulnerabilities. My current research focuses on utilizing patient-derived organoid models
to define epigenetic subtypes of castration resistant prostate cancer (CRPC) and determining the dependency
on transcription factors to mediate growth and lineage identity. My proposed research and mentoring plan will
provide me with a strong foundation towards becoming an independent investigator in academia. My long-term
career goal is to advance personalized cancer medicine, with specific interests in disease modeling, functional
characterization of drivers of lineage plasticity, and evaluation of therapeutics to target oncogenic dependency.
To achieve this goal, I have developed a career plan that will ensure my success to becoming an independent
investigator by: 1) bolstering my scientific knowledge and technical expertise, 2) assembling an advisory
committee to oversee my training progress, 3) improving my communication skills, 4) expanding my
professional network, and 4) preparing me for leading and mentoring future trainees.
RESEARCH: Prostate cancer depends on androgen receptor (AR) signaling for growth and survival. The
advent of therapies targeting AR signaling has driven the disease towards AR-independence. Using a
functional genomics approach, we have identified a new epigenetic subtype of CRPC called stem cell-like
(SCL), which is driven by FOSL1 and lacks therapeutic options. Genetic perturbation of FOSL1 and its
cooperating factors YAP/TAZ leads to impaired cell growth and loss of SCL lineage, suggesting that CRPC-
SCL cells are dependent on FOSL1 for survival. Building on these discoveries, in this proposal, I aim to: 1)
Define the role of FOSL1 in mediating lineage plasticity and resistance to enzalutamide in prostate cancer and
2) Evaluate therapeutics to target the YAP/TAZ/TEAD/FOSL1 pathway in the stem cell-like subtype of prostate
cancer.
ENVIRONMENT: The Yu Chen laboratory is a part of the HOPP under the leadership of Dr. Charles Sawyers
at Memorial Sloan Kettering Cancer Center, a top-tier institute in cancer research. The primary mentor is Dr.
Yu Chen, a pioneer in developing prostate cancer organoids from patients and an expert in the study of
epigenetics and aberrantly activated transcriptional programs. Furthermore, my advisory committee and
collaborator will provide additional support for the proposed research and career development plans.

Public health relevance
PROJECT NARRATIVE Prostate cancer relies on androgen for growth and is therefore sensitive to androgen-deprivation therapy and antiandrogens. However, the disease can develop therapeutic resistance by transforming from a prostate lineage to a stem cell-like state. This project seeks to characterize the molecular drivers of lineage transformation and resistance to antiandrogens, with the goal to develop an effective therapeutic strategy to target these drivers and suppress the growth of stem cell-like prostate cancer.